Scientific Information Management and Literature-Based Evaluations for the DTT - Support for External Peer Review

Several complex scientific reports are prepared under this contract on the Report Preparation project. Coordination of peer review of these reports includes managing a directory of scientific experts, conflict of interest screening for reviewers and companies with potential financial interest, and compiling documents for internal Division of Translational Toxicology record keeping. Peer reviews conducted under this project included NTP Technical Reports on sulfolane and alpha-pinene; an NTP Toxicity Report on phenolic benzotriazoles; an NTP Developmental and Reproductive Toxicity (DART) Technical Report on 2-hydroxy-4-methoxybenzophenone; and an updated edition of the Handbook for Preparing Report on Carcinogens Monographs. Keywords: peer review.